Donor nonclassical monocytes initiate lung injury following transplantation

The indications for lung transplantation have expanded significantly, resulting in a clinical growth of over 50%
in the last decade. However, the survival following lung transplant is the worst compared to other solid organs
with only 80% and 50% of patients alive at 1 and 5 years, respectively. Primary graft dysfunction (PGD),
resulting from ischemia-reperfusion injury, affects over 50% of recipients within 24 hours of transplantation and
has emerged as the most important risk factor for both short-term mortality as well as long-term graft loss from
chronic rejection. As such, therapies directed to ameliorate PGD have the highest potential for improving lung
transplant outcomes. Prior reports have demonstrated that recruitment and extravasation of neutrophils into
the allograft is necessary for the development of PGD. Depleting neutrophils can ameliorate PGD, but is not
clinically feasible given their importance in pathogen clearance. Accordingly, we have focused on
understanding the mechanisms that drive neutrophil recruitment to the lung following transplantation. We
discovered that orphan nuclear receptor (NR4A1)-dependent non-classical monocytes (NCM), characterized
by CD14dimCD16++ in humans and Ly6ClowCX3CR1highCCR2- in mice, are bound to the pulmonary endothelium
via a leukocyte integrin (lymphocyte factor associated antigen-1) and retained in the donor lungs despite the
current techniques for organ perfusion. Following murine and human lung transplant, activated donor-derived
NCM mediate neutrophil recruitment and extravasation into the allograft through mechanisms that remain
unknown. Our published and preliminary data suggest that activation of toll-like receptors in donor-derived
NCM leads to the production of neutrophil chemoattractant, macrophage inflammatory protein 2 (MIP-2). The
donor NCM also release IL-1 and contribute to enhanced vascular permeability in the allograft. Importantly,
using a genetic lineage tracing system we found that donor-derived NCM also migrate to distant organs after
transplant where they recruit neutrophils. Collectively, these data support our hypothesis that donor-derived
NCM are activated following lung ischemia-reperfusion, drive neutrophil influx into the allograft, and promote
secondary injury to distant organs. We have developed a model of murine vascularized orthotopic lung
transplantation where lungs from NR4A1-deficient donor mice, which selectively lack NCM, can be
reconstituted with fluorescent wild-type or genetically mutated NCM to study the signaling pathways in
donor-derived NCM and their contribution to lung IRI. Accordingly, we will dissect the molecular
mechanisms underlying NCM-mediated injury in the allograft and bystander tissues. We will determine: 1) The
toll-like receptors responsible for the activation of donor NCM, 2) Mechanisms through which donor NCM
migrate to distant organs and mediate bystander injury, 3) The role of inflammasome-dependent production of
IL-1 by NCM in mediating neutrophil extravasation. Through these experiments, we will identify pathways that
could be clinically targeted, prior to transplantation, to ameliorate PGD without causing recipient toxicity.

Public health relevance
PROJECT NARRATIVE Freshly transplanted lungs frequently experience a form of acute injury, mediated by the neutrophils of the recipient, which is the predominant cause of both short- and long- term mortality following lung transplantation. We will examine the mechanisms by which pulmonary intravascular nonclassical monocytes, which we recently discovered to be retained in donor lungs, recruit neutrophils and cause injury to the transplanted lung. We believe that the completion of this proposal will introduce therapeutic and investigative avenues for the prevention and treatment of this post-transplant lung injury and improve patient outcomes.